Machine learning methods to assess risk for prenatal and neonatal iron deficiency anemia from maternal stress exposure

PROJECT SUMMARY
This K99 application aims to determine biological and behavioral pathways by which maternal psychosocial
stress in pregnancy impacts risk for maternal and infant iron deficiency anemia (IDA). IDA is one of the most
common causes of anemia worldwide, and around 20% of women in the US experience a stressful life event
throughout their pregnancy. Due to the increased iron demands of pregnancy, pregnancy itself poses a
significant risk of IDA, especially for low-income and racially- and ethnically-minoritized women. IDA increases
the risk of adverse pregnancy outcomes and can negatively impact the iron status of the neonate that may
cause irreversible harm to neurodevelopment. There is growing concern that oral vitamin supplementation
might not be enough to counteract the risks of IDA in the context of systemic inflammation, including
inflammation produced by chronic psychosocial stress and subsequent neuroendocrine dysregulation.
Maternal psychosocial stress has been associated with infant iron status previously, but the potential biological
mechanisms are not yet characterized despite the

Public health relevance
PROJECT NARRATIVE This K99 Career Development Award seeks to provide the applicant training in prenatal psychosocial stress and iron assessment, advanced biostatistics focused on machine learning, placental mechanisms of fetal programming, and research with socioeconomically-, ethnically-, and racially minoritized pregnant populations to support the applicant’s transition to research independence. Through the training embedded in this award, the applicant will develop the skills and expertise necessary to build a translational research program within a Developmental Origins of Health and Disease (DOHaD) framework that will examine pathways by which early exposure to psychosocial stress becomes biologically embedded to affect mother and offspring’s mental and physical health. This approach will ultimately identify mechanisms, markers, and modifiable risk factors relevant to maternal health and child development outcomes.